Host pathways regulating Epstein-Barr virus-mediated B cell growth transformation

ABSTRACT
It is our ultimate goal to define the molecular basis for EBV-mediated metabolic control critical for B-cell
tumorigenesis. In this proposal, we will focus on how EBV promotes the balanced upregulation of oxidative
phosphorylation (OXPHOS) and glycolysis supporting B-cell immortalization and tumorigenesis. It is our central
hypothesis that the viral latent transcription factor, EBNA-LP, functions as a mimic of the OXPHOS transcriptional
co-activator PGC-1 while glycolysis and redox balance are maintained through viral upregulation of the lactate
transporters MCT1 and 4. We have formulated our central hypothesis based on preliminary data including
orthogonal approaches that define interactions between EBNA-LP and OXPHOS transcription factors, define a
new post-translational modification on EBNA-LP, and characterize the metabolic consequences of suppressing
viral-mediated lactate export. We found that the viral EBNA-LP protein associates with NRF-1, ERR, and YY-
1 mimicking the cellular co-activator PGC-1. We describe a novel post-translational modification of EBNA-LP,
hydroxyprolination, that we propose is critical for higher order complex formation enabling transcriptional
activation. Balanced with an increase in OXPHOS promoted by EBNA-LP, the upregulation of glycolytic enzymes
by EBNA2 and c-MYC leads to an accumulation of lactate in cells that must be exported to sustain B-cell
proliferation. We found that cellular monocarboxylate transporters, MCT1 and MCT4, are temporally regulated
by EBV to sustain B-cell proliferation through maintaining NAD+/NADH ratios and glutathione levels to counter
the accumulation of reactive oxygen species. Therefore, the rationale for this proposed research is that
understanding how EBV regulates cellular metabolism during B-cell immortalization could reveal novel
therapeutic modalities to target EBV-infected B-cell lymphomas. We plan to test our central hypothesis and
complete the objectives in this proposal through the following two specific aims: i) to determine the molecular
mechanism by which EBNA-LP coordinates EBV-regulated oxidative phosphorylation to immortalize naïve B
cells and ii) to define the viral-mediated mechanism for temporal regulation of the monocarboxylate transporters,
MCT1 and 4, through B-cell outgrowth and the consequences of their antagonism.

Public health relevance
PROJECT NARRATIVE Epstein-Barr virus regulates cellular metabolism to control B-cell proliferation and promote lymphomas. These studies will define the molecular mechanisms underlying how EBV controls B-cell metabolism.